Multivalent antibody cocktail for bacterial endophthalmitis

Project Summary/Abstract
Exogenous bacterial endophthalmitis can occur following ocular surgery, trauma, or ocular injections. The top
causes are coagulase-negative staphylococci (CoNS), Staphylococcus aureus, and Streptococcus
pneumoniae or the closely related oral streptococci. Antibiotics are used to treat endophthalmitis; however,
antibiotics are only able to kill the bacteria and do not prevent or reverse the resultant damage to the eye. Prior
studies of passive immunization of rabbits with antisera against S. pneumoniae virulence factors demonstrated
significant protection to the eye after bacterial challenge of the vitreous humor. Our central hypothesis is that
prophylaxis and treatment with a multivalent antibody targeting the top 3 causes of bacterial endophthalmitis
will aid in ameliorating ocular damage while used in conjunction with an effective antibiotic to kill the bacteria.
We will test this hypothesis by combining 8 antibodies specific against virulence factors of S. epidermidis, S.
aureus, and S. pneumoniae. The antibodies and their Fab fragments will be analyzed for specificity/affinity,
safety, and neutralization of antigens in vitro, then the multivalent cocktail will be administered to rabbits in
prophylaxis and therapy experiments of bacterial endophthalmitis. The goal of this study is to translate the
knowledge gained thus far from prior research on ocular microbiology into a new drug that can be used in
conjunction with antibiotics and that will combat damage and loss of retinal function.

Public health relevance
Project Narrative Bacterial endophthalmitis, an infectious disease of the interior of the eye, can result in permanent sight- threatening damage. Antibiotics can be used to kill the bacteria but cannot prevent already-produced bacterial toxins and host inflammation from causing damage. This research aims to develop an antibody-based drug mixture that can greatly reduce this damage, thus preserving sight.